Accommodation to polychromatic stimuli

A fundamental question in vision research is how the visual system creates and maintains a
clear retinal image of the world. Understanding the oculomotor mechanisms involved in focusing
the retinal image (termed accommodation) can yield insights into how clinical measurements of
visual clarity translate to daily life, how to improve visual technologies like augmented reality,
and how refractive errors such as myopia develop. It is known that accommodation mechanisms
are sensitive to longitudinal chromatic aberration (LCA), which is the inability of the lens in the
eye to bring all wavelengths of visible light into focus at once. This means that in polychromatic
imagery, some wavelengths will always be out of focus. It is commonly assumed that the visual
system prioritizes bringing middle wavelengths into focus on the retina, as it is known to do
when light entering the eye is white and broadband. But it is unclear whether this holds true for
natural, polychromatic light spectra, or what the mechanisms governing accommodation to such
spectra are. The research in this Pathway to Independence proposal aims to quantitatively
model the mechanisms supporting visual accommodation to complex natural imagery. During
the mentored phase, the candidate proposes to probe color-sensitive accommodation
mechanisms by measuring and modeling human accommodative responses to visual stimuli
generated from a variety of skewed light spectra, particularly spectra with disproportionate
energy at long or short wavelengths. During the independent phase, the candidate proposes to
build principled statistical models relating accommodative behavior to the joint statistics of
spectral power and depth in natural scenes. The candidate will then expand the scope of the
research to study how spatial and color variations in natural scenes interact to impact
accommodation. He will build models of accommodative mechanisms that account for the
impact of these variations. Understanding how these mechanisms operate under natural
conditions will improve our scientific understanding of vision and can support improved
procedures for assessing and achieving visual clarity.

Public health relevance
PROJECT NARRATIVE Maintaining clarity of vision is one of the most important tasks performed by the visual system. This is achieved through the oculomotor process of accommodation. The proposed research will evaluate how accommodation is influenced by properties of natural images such as variation in the spectra of light entering the eye, as well as variation in the spatial properties of the imagery.